NUTRITION TRAINING

Project Summary
The importance of nutritional sciences to improving the public’s health has never been more evident. With
two-thirds of the US population overweight or obese, the burden of chronic diseases, including diabetes, is
increasing and the economic, social and human costs are significant and growing. With initiatives such as
Nutrition for Precision Health, NIH seeks to transform nutritional sciences through innovative research on
nutrition, dietary patterns and the effect of nutrition on the microbiome. There is a continuing national need for
researchers who take a multifaceted approach to solve the most pressing questions, who understand the
translation from basic to clinical levels of inquiry, and who contribute to translation of scientific discovery to
evidence-based nutrition policy and practice. The proposed training program in the Division of Nutritional
Sciences at Cornell University addresses this need by preparing trainees to produce interdisciplinary science
that can drive impact across the translational spectrum from basic sciences to clinical and public health. The
training program, with positions for 4 predoctoral trainees per year, is built on Cornell’s nutrition doctoral
program, which emphasizes multidisciplinary and integrative scholarship across the biological, physical,
behavioral, and social sciences. The 30 trainers participating in this application represent the broad range of
disciplines necessary to achieve the goals of the training program and include renowned scientists with
expertise spanning from genetics, molecular biology and biochemistry to epidemiology, psychology, and
economics. The trainers have active research programs and excellent training records. The proposed training
program includes a core curriculum (Grant Writing and Translational Research and Evidence-based Policy
and Practice in Nutrition) that is complemented by the WHO/Cochrane/Cornell Summer Institute for
Systematic Reviews in Nutrition for Global Policy Making. Trainees also submit an NIH F31 predoctoral
application and participate in three enrichment activities including monthly trainee meetings, hosting an
annual invited speaker, and organizing an annual half-day symposium. As part of the translational research
training, trainees are co-mentored for at least one project in their dissertation. To meet national needs through
doctoral training, the training program includes a combined PhD-RD training component for 1 trainee per year
that comprises the above program elements and a short translational research or policy experience. The
infrastructure to support the proposed training program is well-established, with added strengths from new
faculty members with research programs in molecular nutrition, microbiome, proteomics, computational
biology and nutrition and health inequalities. Highly successful partnerships with the World Health
Organization and Cochrane significantly enhance Cornell’s capabilities in translational science and evidence
synthesis. These new and continuing strengths support the program’s objectives to create an unparalleled
training experience in the nutritional sciences and prepare the next generation of nutrition scientists.

Public health relevance
Project Narrative Over the past 45 years, the NIDDK-supported training program in the Division of Nutritional Sciences has been instrumental in the development of nutrition professionals who hold research positions in academia, government, and industry, and key policy positions in government, international agencies, and nonprofit foundations. The training program is built on the graduate program in nutrition at Cornell University that emphasizes multidisciplinary and integrative scholarship across the biological, physical, behavioral,and social sciences, as appropriate for individual trainees. The NIDDK-supported training program emphasizes translational and collaborative approaches to meet national needs in translational research and includes a combined PhD-RD training program.